Molecular Basis of TDP-43 Proteinopathies: Disease Models and Mechanisms

PROJECT SUMMARY/ABSTRACT Amyotrophic lateral sclerosis (ALS) is a devastating adult-onset neurodegenerative disease that wreaks havoc on motor neurons. A progressive and fatal muscle paralysis ensues, causing death within 2 to 5 years. Recently, a central role for RNA binding proteins and RNA metabolism pathways has emerged. The protein TDP-43 was recently identified as the major disease protein in pathological inclusions in both ALS and frontal temporal lobar degeneration with ubiquitin-positive inclusions (FTLD-U). Moreover, mutations in the TDP-43 gene have now been identified in sporadic and familial ALS patients. Pathology and genetics both converge on TDP-43 being central to the pathogenesis of these diseases. In the first five years of this research project, we have generated in vitro and in vivo TDP-43 proteinopathy models to explore TDP-43. We have harnessed the simple yeast model system to study TDP-43's properties and the effect of ALS-linked mutations. Our preliminary data demonstrate: 1) a critical role for the RNA recognition motif and carboxy-terminal region of TDP-43 in mediating aggregation and cellular toxicity, 2) increased aggregation and toxicity caused by a disease-linked TDP-43 mutation, and 3) genetic screens identified multiple RNA binding proteins as potent toxicity modifiers. One of these, Pbp1, is the yeast homolog of human ataxin 2 and we identified polyglutamine expansions in ataxin 2 as a major genetic risk factor for ALS in humans. We also discovered that deletion of the Dbr1 gene potently suppresses TDP-43 toxicity. The identification of a major genetic risk factor for ALS in humans and a novel and unexpected therapeutic target for ALS starting from the simple yeast model, illustrates the power of this approach. We have also pursued studies beyond TDP-43, focusing on additional RNA-binding proteins, such as FUS, TAF15, EWSR1, and several more. We have discovered a prion-like domain in TDP-43 and FUS and have used this domain to link additional RNA-binding proteins to a class of proteins with similar structural and functional properties. For the next five years of this project, with the goal to define TDP-43 disease mechanisms from multiple angles we propose three Specific Aims: 1) Continuing to characterize hits from our yeast TDP-43 toxicity modifier screens to elucidate additional mechanisms of TDP- 43 toxicity and to perform an additional yeast screen of ~1,000 essential genes; 2) Defining the mechanism by which Dbr1 inhibition suppresses TDP-43 toxicity and extending these studies to mammalian cells and animal models; 3) Testing the hypothesis that aggregation-prone RNA-binding proteins contribute broadly to ALS using next generation sequencing approaches.

Public health relevance
PROJECT NARRATIVE As our population continues to age, neurodegenerative disease will increase in prevalence and thus pose a daunting challenge to public health worldwide. The protein TDP-43 has been implicated in the pathogenesis of amyotrophic lateral sclerosis (ALS) and frontal temporal lobar degeneration with ubiquitin-positive inclusions (FTLD-U), but very little is known about the mechanisms by which TDP-43 causes neurodegeneration. Our project harnesses multiple in vitro and in vivo models and techniques to gain mechanistic insight into how TDP-43 contributes to human disease, which will suggest novel avenues for therapeutic intervention. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This is an application to renew our TDP-43 R01 for another five years of funding, as we continue our mission to mechanistically define how TDP-43 and related RNA-binding proteins contribute to devastating neurodegenerative diseases ALS and frontotemporal dementia. TDP-43 is a nuclear RNA-binding protein but accumulates in cytoplasmic aggregates in the degenerating motor neurons of almost all ALS patients. Moreover, mutations in the TDP-43 gene are a cause of some rare forms of sporadic and familial ALS. How TDP-43 contributes to ALS is not well understood and an area of intense interest. We have been using innovative approaches to gain mechanistic insight into the role of TDP-43 in disease. We created a yeast TDP-43 proteinopathy model to define mechanisms of TDP-43 aggregation and toxicity. We have used this model to elucidate disease-relevant features of TDP-43 that contribute to its aggregation and toxicity and to test the effects of ALS-linked TDP-43 mutations. Very little is known about the cellular pathways affected by TDP-43 (in any cell type, yeast or neuron). To address this, we have performed two genomewide yeast modifier screens using this model and have identified 41 genes that modify toxicity when overexpressed and 13 genes that modify toxicity when deleted. Of these 54 TDP-43 toxicity modifier genes, we have so far only focused on two of them in detail. These two genes are Pbp1, whose human homolog, ataxin 2, we have discovered to be one of the most common genetic risk factors for ALS discovered to date and Dbr1, which we have recently found to be a novel potential therapeutic target for ALS and other TDP-43 proteinopathies. In addition to Dbr1 and ataxin 2, we have identified several other potent modifiers of TDP-43 toxicity and we strongly suspect that some of these will yield powerful insight into TDP-43 biology and pathobiology. Beyond TDP-43, several new RNA-binding have very recently emerged as key players in ALS and FTLD. These include FUS/TLS, TAF15, EWSR1, hNRNPA2B1, and hnRNPA1. We have harnessed the yeast model and human genetics approaches to study these proteins and to predict additional ones that might also contribute to disease. We are very excited about the next five years of this project. Not only will we continue to unravel new insights into how TDP-43 aggregation contributes to disease (combining yeast, human genetics, and other model systems), we will also test the exciting hypothesis that RNA-binding proteins contribute broadly to ALS and related neurodegenerative diseases. Therefore, we propose three Specific Aims: Aim 1: To identify genetic modifiers of TDP-43 aggregation and toxicity. We have performed two TDP-43 toxicity screens in yeast, which have led to unexpected discoveries about TDP-43. We will continue to characterize the hits from these screens. Although these screens have been very fruitful, they have missed an important set of ~1,000 yeast genes - the essential yeast genes (which are not represented in the yeast deletion collection). Utilizing a new library of essential gene mutant strains, we will now perform a screen of this collection for modifiers of TDP-43 aggregation and toxicity. The hits that we identify from our new screen will suggest key pathways that may be affected by TDP-43 aggregation and will complement our existing set of TDP-43 modifiers. We will validate the most effective hits from yeast in mammalian cells and animal models. Aim 2: To define the mechanism by which Dbr1 inhibition protects against TDP-43 toxicity. We recently discovered that deleting Dbr1 in yeast results in protection against TDP-43 toxicity. Dbr1 encodes RNA lariat debranching enzyme. In its absence, intronic lariats accumulate at high levels. We found that these lariats act as decoys for TDP-43, causing it to bind to the innocuous lariats and preventing them from interfering with essential cellular RNAs and RNA-binding proteins. We will perform experiments to determine the sequence or structural features of lariats that attracts TDP-43. We developed a method to visualize lariats in living yeast cells. We will use a similar approach to visualize lariats in mammalian cells and we will test the effect of Dbr1 inhibition in a fly TDP-43 model. Aim 3: The iceberg emerges: testing the hypothesis that aggregation-prone RNA-binding proteins contribute broadly to ALS and related neurodegenerative diseases. Our studies with TDP-43 and FUS/TLS in yeast have led to an intriguing hypothesis: perhaps other RNA-binding proteins with similar properties as TDP-43 and FUS/TLS also contribute to ALS. Exciting new developments from my laboratory and our collaborators' laboratories suggest that such RNA-binding proteins (e.g., TAF15, EWSR1, hnRNPA2B1, hnRNPA1) might contribute broadly to ALS and related disorders. We will test this hypothesis using next generation sequencing approaches to perform a comprehensive analysis of aggregation-prone RNA-binding protein genes in a large number of ALS cases and controls.